RGS10 in microglia activation and dopaminergic neuron survival

DESCRIPTION (provided by applicant): Microglia are brain-resident macrophages responsible for immune surveillance. These cells become activated in response to injury, infection, environmental toxins, and other stimuli, thereby critically influencing neuronal survival and brain function. A wealth of clinical and experimental data implicate chronic microglia activation and overproduction of inflammatory mediators in the pathogenesis of Parkinson's disease (PD), the pathological hallmark of which is loss of ventral midbrain dopaminergic (DA) neurons that control output from motor cortex. However, the key molecular regulators of neuroinflammatory responses in the ventral midbrain have yet to be identified. The goals of this proposal are to investigate the role of Regulator of G-protein Signaling (RGS)-10, a GTPase Accelerating Protein (GAP) enriched in microglia, in neuroinflammatory responses that influence the vulnerability of nigral DA neurons to inflammation-induced degeneration. In Specific Aim 1 we will investigate the role of RGS10 in microglia activation and impact on survival of dopaminergic neurons using cell-based and rodent models. In Specific Aim 2, we will define the molecular mechanism and signaling pathways involved in RGS10-dependent regulation of activation responses and gene expression in microglia using cell-based models. In Specific Aim 3 we will investigate the extent to which aging and neurodegeneration affect mouse and human RGS10 expression in microglia and peripheral macrophages. Completion of the proposed experiments will provide new information regarding the function of RGS10 in microglia and in neuroinflammatory responses in the ventral midbrain and may reveal novel targets for development of new therapies to prevent or treat PD, the second most common neurodegenerative disorder in the U.S.

Public health relevance
PUBLIC HEALTH RELEVANCE: Parkinson's disease (PD) is the second most common neurodegenerative disease in the U.S. affecting 1-2% of individuals over age 60. Inflammatory processes have been strongly implicated in the pathogenesis of PD. The proposed studies will determine the role of RGS10 in microglia activation responses in protecting dopaminergic neurons against inflammation-induced degeneration. Completion of the proposed experiments may reveal new targets for therapies to prevent or delay development of PD in humans. Project Narrative Parkinson's disease (PD) is the second most common neurodegenerative disease in the U.S. affecting 1-2% of individuals over age 60. Inflammatory processes have been strongly implicated in the pathogenesis of PD. The proposed studies will determine the role of RGS10 in microglia activation responses in protecting dopaminergic neurons against inflammation-induced degeneration. Completion of the proposed experiments may reveal new targets for therapies to prevent or delay development of PD in humans. __SpecificAimsTextDelimiter__ Specific Aims Neuron-glia interactions are complex and critical for neuronal development, survival, and function. As the brain resident macrophage, microglia are responsible for immune surveillance, becoming activated in response to injury, infection, environmental toxins, and other stimuli that threaten neuronal survival [1, 2]. While the outcome of their activation is initially adaptive, under certain circumstances the products of activated microglia can be toxic to neurons [1, 2]. We and others have shown that dopaminergic (DA) neurons in the ventral midbrain substantia nigra pars compacta (SNpc) are particularly sensitive to the toxic effects of microglia-derived factors such as Tumor Necrosis Factor (TNF) [3-6], implicating a role for inflammation in the pathogenesis of Parkinson's disease (PD) [7, 8]. Thus, mechanisms that regulate microglia function and neuroinflammatory processes in the ventral midbrain are of relevance to our understanding of this progressive neurodegenerative disease. In recent years, much progress has been made in defining the heterogeneity of microglia phenotypes and function within the CNS [9]; however, identification of key molecular regulators of midbrain microglia activation responses during chronic neuroinflammation have yet to be elucidated. In preliminary data and a published manuscript [10], my group has discovered that the GTPase Accelerating Protein (GAP) Regulator of G-protein Signaling (RGS)-10 is enriched in microglia and may be a critical determinant of microglia activation. Specifically, we have discovered that mice lacking RGS10 have: i) increased microglial burden in the CNS from birth, ii) an exaggerated inflammatory response to chronic systemic inflammation, and iii) increased inflammation-induced nigral DA neuron loss compared to wild-type mice. We have also discovered that inflammatory stimuli induce nuclear enrichment of RGS10, an observation that points toward a novel, non-GAP mechanism for RGS10 regulation of microglia. On the basis of these preliminary findings we hypothesize that RGS10 is a critical regulator of microglial activation responses that affect DA neuron survival. To test this hypothesis directly, we propose the following specific aims: AIM 1: Investigate the role of RGS10 in microglia function and impact on midbrain DA neurons. Can selective manipulation of RGS10 within microglia modulate specific effector functions that protect DA cells from various death-inducing insults? A. Measure inflammatory factor production and cytotoxicity on DA cells after partial or full ablation of RGS10 in microglia. B. Determine whether restoration of microglial RGS10 in Rgs10 null mice rescues 1) the microglia phenotype and 2) inflammation-induced degeneration of nigral DA neurons. C. Investigate whether over-expression of RGS10 in microglia protects DA neurons against 6-OHDA-induced cell death. Normalmicroglia Chronicallytaxedmicroglia AIM 2: Define the mechanisms through which RGS10 regulates microglia activation. Microglia LPS LPS activation and inflammation-related gene expression are critically regulated by p38MAPK, NFkB and CREB signaling pathways. Because Rgs10-null mice display heightened neuroinflammation, the goal of AIM2 is to begin identifying the network of RGS10 targets in microglia. CREB NFkB CREB NFkB A. Determine whether RGS10 GAP activity is required. B. Determine whether RGS10 negatively regulates p38MAPK signaling. ? ? C. Determine whether RGS10 associates with CREB NFkB CREB NFkB diffusible second messengers and translocates to the nucleus to form regulatory complexes with Normalinflammatorygene ENHANCEDinflammatorygene transcription factors NFkB and/or CREB. transcription transcription AIM 3. Determine whether RGS10 levels in microglia/macrophages change as a function of age, neurodegenerative status, and in response to chronic systemic inflammation. Given that age is the greatest risk factor in idiopathic PD, it is likely that aging decreases the levels of protective factors in the CNS, thus predisposing an individual to neurodegeneration or susceptibility to inflammation. Thus, we will: A. Investigate the relationship between levels of microglial RGS10 and microglia activation status in the brain and in peripheral macrophages as a function of age and neurodegeneration status in mice and human samples. B. Investigate the extent to which chronic systemic (gut) inflammation, known to trigger neuroinflammation, reduces RGS10 levels in brain microglia/peripheral macrophages in old vs. young mice. Cytosol Nucleus Completion of these studies will provide new information on the role of RGS10 in neuroimmune regulation and its relationship to DA neuron survival and may reveal novel cell-type specific targets for development of new therapies to prevent or treat PD, the second most common neurodegenerative disorder in the U.S.